TRD 3: MRI parameters reflecting tissue composition and microstructure

TRD3: MRI parameters reflecting tissue composition and microstructure
Lead Principal investigator: Peter van Zijl, Professor of Radiology
Co-investigators: Xu Li, Manisha Aggarwal, Hye-Young Heo, Jeremias Sulam, Susumu Mori
Consultant: Filip Szczepankiewicz (Lund University)
While TRDs 1 and 2 focus on MR approaches that measure actual physiological constants and metabolite
signals, the definition of a Quantitative Imaging Biomarker (QIB) goes much further. In TRD3 we therefore
exploit the inherent power of MRI to probe tissue composition and microstructure, the characteristics of
which can be accessed through a multitude of MRI phenomena and parameters that can be seen as
candidate biomarkers. The intensity and frequency of the water signal in an MRI voxel depend on the
local microscopic fields and field differences imposed by tissue compartments and molecules. In addition,
the motion of water measured by MRI is affected by compartment size and permeability, which may
change in disease and thus contain potential biomarker information. The overall goal of this TRD is to
design pulse sequences and analysis approaches to efficiently quantify MRI parameters that assess
tissue composition and microstructure. We have the following specific aims:
AIM 1: Development of compartmental filtering and diffusional encoding methods to probe tissue
microstructure.
AIM 2: Development of integrated susceptibility and diffusion tensor imaging (STI and DTI) for fiber
tractography, aiming at high resolution white matter fiber tractography in vivo. Gray matter iron content
and blood oxygenation will also be assessed from these high-resolution susceptibility images
AIM 3: Development of fast multi-parameter acquisition and analysis approaches for simultaneous
quantification of the MR-derived parameters in Aims 1 and 2 plus T1, T2(*), and Magnetization Transfer
Ratio (MTR).
The parameters obtained will be used to synthetically generate multiple image contrasts (synthetic MRI),
including conventional ones with which the radiologists are familiar for reading and that currently can be
acquired only separately. Eight CPs will be involved in optimizing the methods and testing these approaches
for biomarker potential. Eight SPs will use them to extend the information content in their studies. The
developed tissue markers together with the diagnostic parameters of TRD1 and TRD2 will be made available
to TRD4, which will develop statistical and deep learning technologies to combine them and make them
available in age-dependent multi-parameter brain atlases.

Public health relevance
The overall goal of this project is to design pulse sequences and analysis approaches to efficiently quantify MRI parameters that reflect tissue composition and microstructure. These parameters will be used to synthetically generate multiple image contrasts (synthetic MRI), including conventional ones with which the radiologists are familiar for reading and that currently can be acquired only separately. In addition we will develop methods for high resolution mapping of white matter brain tracts.